Core A - Administrative Core

Project Summary – Core A
This Phase II Center of Biomedical Research Excellence (COBRE) proposal will sustain and enhance an
interdisciplinary research Center within the University of Nevada, Reno (UNR) focused on fundamental molecular
and cellular signal transduction mechanisms in the cardiovascular system. Core A, the Administrative and
Faculty Development Core, is described here. Core A will manage the COBRE’s administrative, fiscal, and
scientific activities. Core A will be directed by Dr. Scott Earley, Professor of Pharmacology, the Principal
Investigator and COBRE Director. Dr. Earley is an accomplished investigator with an established track record of
NIH funding, publication in high-quality journals, and committed to mentoring young scientists. The following
goals have been established for Core A during Phase II: 1) Provide scientific leadership and develop an
administrative structure for the Center; 2) Execute an aggressive Faculty Development Plan to provide
personalized, one-on-one mentoring for the COBRE’s Research Project Leaders (RPLs). The Faculty
Development Plan is designed to transition the RPLs from early career investigator status to fully independent
research scientists funded by their own Research Project Grants (RPGs), such as an NIH R01 or equivalent; 3)
Select and recruit new RPLs to replace those who graduate; 4) Establish an effective Pilot Projects Program to
fund the development of new research projects; 5) Establish and coordinate an effective Advisory Committee;
6) Plan for the long-term sustainability of our Center; and 7) Implement a formative and summative evaluation
strategy for the COBRE, the RPLs, and the Research Cores with specific milestones. Completing these goals
will sustain and enhance the Nevada COBRE in Molecular and Cellular Signal Transduction in the
Cardiovascular System as an internationally recognized, sustainable multidisciplinary research Center
investigating the regulation of cardiovascular function during health and disease.

Public health relevance
Project Narrative – Core A The goal of this proposal is to sustain and enhance the Administrative and Faculty Development Core (Core A) of a Phase II Center of Biomedical Research Excellence (COBRE) that is focused on molecular and cellular signal transduction in the cardiovascular system within the University of Nevada, Reno (UNR). Core A houses the infrastructure to manage administrative, fiscal, and scientific aspects of the COBRE; execute a Faculty Development Plan to promote the rapid development of the COBRE’s Research Project Leaders (RPLs) from early-stage investigators to fully independent research scientists; continuously track and evaluate the progress of RPLs to scientific independence; establish and execute a Pilot Projects Program; and track and assess the success of the Research Cores.